A Social-Ecological Approach to Identify Nursing Models of Care to Reduce Emergency Department Disparities

Project Summary
Candidate: To achieve her career goal of becoming an independent investigator, K. Jane Muir, PhD, APRN,
FNP-BC seeks mentored research training in health equity research, machine learning techniques, and causal
inference approaches. This career development award identifies modifiable nursing features to improve
emergency department (ED) patient outcomes with a focus on reducing patient outcome disparities.
Research Context: Hospital EDs have the potential to save lives, but pervasive delays and chaotic aspects of
emergency care place patient’s health outcomes at risk while widening disparities in care for racial and ethnic
minorities. Registered nurses direct all processes of care in hospital EDs including triage, throughput, and
patient disposition, yet few studies have determined whether they are adequately resourced to do so.
Grounded in the Social Ecological Model, this study aims to determine the extent to which hospital nursing
models of care are associated with patient outcomes and disparities to improve ED care outcomes.
Specific Aims. 1) To determine which nursing models of care (defined by different combinations of ED and
inpatient nursing resources) are associated with ED patient outcomes; 2) To determine the association of
nursing models of care on ED patient outcome disparities.
Research Plan: Datasets include, 1) Penn’s Nurses4All multi-state nurse survey, 2) the American Hospital
Association Annual Hospital Survey, 3) AHRQ Healthcare Cost Utilization Project patient database. In Aim 1,
machine learning will be used to identify nursing models of care characterized by ED and inpatient nursing
resources (nurse staffing levels, nurse work environments, skill mix, nurse practitioners) associated with ED
patient outcomes (ED length of stay, ED revisits, disposition against medical advice, 30-day hospital
readmissions, in-hospital mortality) in hospitals overall with separate comparisons among minority share and
non-minority share hospitals. In Aim 2, disparities in ED patient outcomes associated with nursing models of
care will be examined among racial/ethnic minority patients compared to Whites.
Career Development Plan: With an interdisciplinary and experienced team of mentors, Dr. Muir will pursue
didactics, seminars and conferences to complete the training goals, which are to 1) cultivate and apply
expertise in the theory, design, and evaluation of research advancing health equity; 2) apply advanced
machine learning techniques to develop hospital nursing models of care defined by combinations of ED and
inpatient nursing resources; 3) expand and apply skills in causal inference approaches with observational data.
Environment: The University of Pennsylvania School of Nursing offers an ideal environment to pursue the
proposed training and research. Dr. Muir is well-positioned to successfully complete the proposed aims and
training because of her experienced mentorship team and extensive resources for career development.

Public health relevance
PROJECTIVE NARRATIVE This study will leverage nursing models of care to advance better patient outcomes with a focus on reducing patient outcome disparities in the safety net of the U.S. healthcare system—hospital emergency departments (EDs). The outcomes from this study will address a key objective of Healthy People 2030 to improve care in EDs where timely care is essential for improving health outcomes. This study has strong public health relevance given the focus on hospital EDs as important care settings in communities that provide a large proportion of care for under- and un-insured patients as well as racial and ethnic minorities.